Project 2: Patterns of Care and Patient Experiences During Early Survivorship Among AYA Cancer Survivors

ABSTRACT – Project 2, Patterns of Care and Care Transitions in AYA Cancer Survivors
Each year, almost 70,000 AYAs aged 15-39 years are diagnosed with cancer in the United States, yet
little is known about their patterns of post-treatment healthcare utilization, care experiences, or patient-reported
outcomes. Prior research demonstrates that AYA survivors may experience multiple challenges during post-
treatment care, including poor continuity of care, inadequate patient-provider communication, and receipt of
suboptimal post-treatment healthcare services despite available national clinical care guidelines. To advance
research, impact clinical guidelines, and improve AYA cancer care, we need evidence on patterns of care,
patient healthcare experiences and barriers to care, and patient-reported outcomes among AYA
survivors, particularly during the transition to early survivorship. To address gaps in current knowledge,
our project aims to: 1) evaluate patterns of outpatient, emergency, and inpatient service utilization among AYA
survivors and determine variations by patient-, provider-, and system-level factors; 2) examine patient-reported
care experiences and barriers to care, focusing on perceived coordination of care and communication with
providers; and 3) determine the relationship between receipt of guideline-concordant outpatient services and
patient-reported outcomes. We will leverage data from AYA survivors 2–5 years post diagnosis from
integrated healthcare systems, state-based data resources, and patient surveys. In Aim 1, we will use data
from >60,000 AYA survivors from five large-scale geographically diverse data resources, including Kaiser
Permanente Northern and Southern California (KPNC, KPSC) electronic health records and research
databases, the California and Utah Cancer Registries linked to corresponding state hospitalization databases,
and linked data from the North Carolina Cancer Registry and administrative claims. We will use these
population-based data to evaluate patterns of care among individuals diagnosed between 2006 and 2016 with
the 10 most common AYA-onset cancers. In Aim 2, we will use data from the P01 Survey of 5,000 AYA
cancer survivors from KPNC, KPSC, and North Carolina populations to describe care experiences 2–5 years
post diagnosis. In Aim 3, we will determine concordance of post-treatment care for four cancer types
(N=6,281) with national guidelines and evaluate the association of guideline-concordant care measured
through KPNC and KPSC electronic databases with patient-reported survey-based outcomes. This innovative
study will be among the first to examine the transition to early survivorship care in a large and diverse AYA
population. Our project aims and analyses are central to our P01 program and complement other projects
through focus on similar cancer sites in subgroup analyses (Project 1, 3) and by providing datasets classifying
guideline concordance for other analyses (Project 3). Collectively, our results will advance the state of AYA
research, inform clinical guidelines, and provide actionable findings for patient-, provider-, and system-level
interventions to improve care quality and outcomes among AYA cancer survivors.

Public health relevance
PROJECT NARRATIVE – Project 2, Patterns of Care and Care Transitions in AYA Cancer Survivors The goal of this project is to investigate patterns of healthcare utilization among adolescent and young adult (AYA) cancer survivors, assess patient-reported care experiences and barriers to appropriate care during early survivorship, and understand associations between concordance with national clinical care guidelines and patient-reported outcomes. We will use data from multiple healthcare systems and state-based resources and reports from AYA cancer survivors themselves to generate essential insights to improve care and outcomes for this population.